2022 Biology of Host-Parasite Interactions GRC and GRS

Project Summary
The 2022 GRC on the Biology of Host-Parasite Interactions will focus on the most recent molecular and
translational advances in parasitic diseases. A wide range of human and veterinary pathogens that cause malaria,
toxoplasmosis, trypanosomiasis, leishmaniasis, amoebiasis and worm infections will be emphasized, with the
aim of bringing together scientists from all over the globe to share and synthesize knowledge. The ultimate goal
will be to improve the fundamental understanding of these parasites as well as to contribute to the design of
future control and elimination efforts. A wide range of topics will be covered at the conference, including sexual
differentiation and quorum sensing, immunology and immune-suppression, genome instability, parasite motility,
dormancy and persistence, molecular biology and gene expression, host cell responses and manipulation by
parasites, and metabolism and drug targets. Additionally, the program will also include a session on effective
scientific communication with the general public and government officials. The breadth of this meeting is unique
in the field, and it is the only recurring meeting that provides an opportunity for investigators working on both
worm and protozoal pathogens to interact with immunologists and medicinal chemists. The meeting also
provides academic scientists the opportunity to compare approaches with investigators working within the
pharmaceutical industry. The program has been designed to cover this broad range of topics and we have
commitments from top scientists in the field to attend and speak. In addition, we will select short talks from
abstracts, which will broaden diversity. There will also be preceding Gordon Research Seminar (GRS), which
offers a unique opportunity for postdocs and graduate students to organize their own conference, to present their
work through talks and posters, and to exchange ideas at the forefront of research in a serene but stimulating
atmosphere at the Salve Regina University Campus, Newport. Talks for the GRS will be selected from submitted
abstracts reporting latest ground-breaking findings. Students, post-docs and early career scientists are strongly
encouraged to apply to both the GRC and GRS. Special efforts are being made to raise funds to provide
individuals from endemic countries with support.

Public health relevance
Project Narrative Diseases caused by infection with parasites inflict a tremendous toll on human health both nationally and globally. Many of the diseases caused by these organisms remain neglected despite the substantial burden they inflict on large regions of the world. The GRC/GRS brings together experts in the field, across labs and institutions worldwide to discuss cutting-edge research to address this need.